Administrative Core

PROJECT SUMMARY (See instructions): The P30 Core Center requires administrative assistance beyond that provided by indirect costs. The Administrative Core supports the Core Center PI, Peter G. Gillespie, for management. In addifion, the Administrative Core supports the activities of an Administrator and a Financial Analyst, who manage the day-to-day administrative load of the Core Center.

Public health relevance
This P30 Core Center supports 20 investigators who carry out research into the basic and disease mechanisms of hearing, balance, and smell. The Administrative Shell increases the efficiency of their research programs.